PHARMACODYNAMICS OF ADJUSTED DOSE SUBCUTANEOUS HEPARIN AND IMPLICATIONS

To define the time of onset and duration of subtherapeutic anticoagulant effect following subcutaneous administration of weight based unfractionated heparin in healthy volunteers.